Nonhuman Primate Testing Center for Evaluation of Somatic Cell Genome Editing Tools: Antibodies Supplement

PROJECT SUMMARY / ABSTRACT
The Nonhuman Primate Testing Center for Evaluation of Somatic Cell Genome Editing Tools supports studies
with nonhuman primates that will advance the genome editing field, and significantly contributes to the future
translation of these technologies for the treatment of human disease. The Nonhuman Primate Testing Center
includes a robust team and partnerships that capitalize on major strengths including the California National
Primate Research Center, Genome Center, and Clinical and Translational Science Center. The Nonhuman
Primate Testing Center offers state-of-the-art capabilities for Somatic Cell Genome Editing (SCGE)
investigators to conduct high quality research in nonhuman primates. The Testing Center leverages a
supportive framework that has demonstrated a long-standing commitment to providing research opportunities
and collaborations to investigators nationwide. Through this powerful infrastructure the Testing Center fosters
partnerships with SCGE awardees through provision of expertise, resources, and collaborative opportunities
that accelerate their research, and ensures synergism across the SCGE Consortium and with ongoing
interactions with the Dissemination and Coordinating Center. This supplement supports a key collaborative
project that will result in new opportunities with broad applications for the gene therapy and somatic cell
genome editing fields, and will be conducted utilizing all of the capabilities of the Nonhuman Primate Testing
Center for Evaluation of Somatic Cell Genome Editing Tools.

Public health relevance
PROJECT NARRATIVE The Nonhuman Primate Testing Center for Evaluation of Somatic Cell Genome Editing Tools serves the Somatic Cell Genome Editing community and the public by supporting studies in nonhuman primates that will advance the field. Through these efforts the Nonhuman Primate Testing Center will significantly contribute to the future translation of cutting-edge technologies for the treatment of a range of rare and common human diseases.